Auditory Cortical Processing in Hearing Loss

PROJECT SUMMARY
The proposed experiments aim to determine how the consequences of asymmetric hearing loss (AHL)
in auditory cortex affect the neural processes that allow listeners to parse and decode foreground sounds in
background noise. AHL is one of the most common forms of hearing impairment, and it profoundly disrupts
spatial hearing and the ability to process signals in noise (SIN). Disabilities across hearing domains are
generally more severe in AHL patients than in equivalent cases of symmetric sensorineural hearing loss
(SNHL). Thus, AHL has broad implications for health, including tinnitus, cognitive impairment, and reduced
quality of life. We recently discovered that the cortical hemispheres ipsilateral and contralateral to the hearing
loss recover differently after asymmetric acoustic trauma. Specifically, spectral preferences for sounds
emanating from the two ears realign in the contralateral hemisphere within ~6 months after AHL but remain
misaligned in the ipsilateral hemisphere. Neither the dynamics nor the functional consequences of these
hemispheric differences on SIN processing or crucial auditory functions such as central gain adaptation are
known. Furthermore, we recently discovered that neurons in normal auditory cortex are considerably diverse in
how well they tolerate background noise. Some neurons actually improving their processing in the presence of
noise. This diversity creates an opportunity to identify the factors that determine the noise tolerance of cortical
neurons and the consequences of AHL.
We propose to conduct a multifaceted, longitudinal analysis of bilateral cortical reorganization following
AHL. The role of inhibitory interneurons is of special interest because inhibitory dysregulation has been
implicated as both a cause and consequence of hearing loss. Our Aims will determine (1) how AHL affects the
sensitivity to background sounds in the cortical circuits, (2) how AHL affects the ability of cortical neurons to
adapt to changes in stimulus level and contrast, and (3) how functional changes in AHL relate to the structural
and functional expression of inhibition in cortical networks. We will estimate spectral and temporal tuning
properties, excitatory-inhibitory balance, and temporal context capabilities, which are all critical for optimal
speech perception. We will provide the first examination of disrupted cortical SIN processing in AHL by
studying monaural and binaural signal decoding abilities over a range of competing background noise levels.
We will relate the degree and time course of AHL-induced functional processing changes to neuroanatomically
determined alterations in the interneuron density across core cortical fields in the two hemispheres. The wealth
of new insights generated by this approach will resolve numerous outstanding questions regarding central
reorganization in AHL and its dynamic time course, equip clinical researchers with new and better-defined
central biomarkers of AHL, facilitate the development of improved rehabilitation strategies, and provide a new
way to understand how the brain extracts signals from noise in normal and impaired hearing.

Public health relevance
PROJECT NARRATIVE The principal difficulty faced by people with asymmetric peripheral hearing loss is a reduction in speech comprehension due to the competing background noise present in typical listening environments. This project explores the consequences of asymmetric hearing loss on hemisphere-specific cortical stimulus coding principles that enable robust signal-in-noise processing. Knowledge of these principles will guide the development of novel therapeutic approaches to communicative disorders, such as possibilities of behavioral training, algorithms for noise reduction in hearing aids, and stimulation protocols for neural prosthetic devices for hearing.